Isoform- and Sex-Specific Functions of CGRP in Gastrointestinal Motility

PROJECT SUMMARY
Calcitonin gene-related peptide (CGRP) is secreted by neurons and is important for vasodilation,
nociception, and immune responses. Drugs targeting CGRP have been a breakthrough in the treatment of
migraine headaches. Increasing clinical evidence suggests that CGRP signaling may also be involved in
gastrointestinal (GI) health and disease. For example, constipation is one of the most common side effects of
the new anti-CGRP therapies, hinting that this signaling pathway is important for normal gut motility.
Converging with the real-world experience of migraine patients, three genome-wide association studies
recently identified the CALCB locus as strongly linked to stool frequency and diverticular disease. CALCB
encodes the β-isoform of CGRP, which is highly conserved between humans and mice. The functional
significance of CALCB in the bowel, however, has not been identified. The overarching goal of this proposal
is to define the enteric neurons that secrete CALCB and determine which aspects of GI motility that CALCB
signaling is necessary for in vivo.
CALCB and CALCA, the α-isoform of CGRP, differ by only 3 amino acids making it challenging to
distinguish them at the protein level by immunohistochemistry or ELISA. The two isoforms are encoded by
distinct loci, however, enabling their expression to be readily distinguished at the transcript level. Previous
gene expression studies showed that while CALCA is the major CGRP isoform in most of the body, CALCB
dominates in the intestine. Despite this dominance, virtually all of the studies that have probed the roles of
CGRP in gut immunity and visceral pain have identified CALCA originating from gut-extrinsic afferent neurons
as the key isoform and found CALCB to be dispensable, leaving its essential functions unclear. Utilizing the
anti-CGRP agents in clinical use as well as new genetic tools that we have generated to enable selective
labeling and manipulation of CALCB neurons in the enteric nervous system (ENS), we will accomplish three
objectives. One, determine which segments of the GI tract require CALCB, the major ENS-derived CGRP, for
normal motility in mice. Our preliminary data show that these requirements are sex-specific, suggesting that
the cellular-molecular wiring of the CGRP pathway in the intestine may be different in males and females. Two,
using genetically encoded reporters, calcium indicators and chemogenetic proteins, we will define the neurons
in the male and female ENS that release CALCB and how gut motility is affected by altering their activity.
Three, given the accumulating evidence for CGRP involvement in GI homeostasis, we will determine the
mechanisms that regulate the intestinal levels of both isoforms. In addition to advancing the fundamental
understanding of neuromuscular function in the bowel, the impact of this work will be to explain how a widely
used class of drugs causes adverse GI effects and, conversely, if isoform- or ENS-specific targeting of CGRP
signaling may be beneficial for treating GI dysmotility.

Public health relevance
PROJECT NARRATIVE Medications targeting the CGRP signaling pathway are increasingly used for migraine headaches, but constipation is a common side effect. CGRP is produced by an important group of nerve cells in the intestine, but its functions in these cells are not clear. This proposal aims to determine how intestinal CGRP and the nerve cells that make CGRP regulate gastrointestinal (GI) motility; this knowledge will help minimize side effects of anti-CGRP medications and show whether they could be used to treat GI dysmotility.